Cellular Metabolites regulating cancer cell adaptation

PROJECT SUMMARY
Cellular metabolites regulating cancer cell adaptation
SAICAR is a metabolite accumulates in cancer cells upon glucose starvation or EGF stimulation. Upon
accumulation, SAICAR promotes cancer cell survival and proliferation by inducing tumor PKM2. However, it is
not yet clear how cancer cells, but not normal proliferating cells, accumulate SAICAR.
We hypothesize that transformation-induced alteration of pentose phosphate pathway is responsible for
the accumulation of SAICAR. In this project, we will test this hypothesis while evaluating the importance of
SAICAR accumulation for the growth of tumor in vivo.
The outcome of this project include a better understanding on metabolic reprogramming contributes to
cancer. In addition, the outcome of this project will determine whether SAICAR accumulation can be a potential
therapeutic target.

Public health relevance
PROJECT NARRATIVE SAICAR is a nucleotide biosynthesis metabolite whose accumulation induces the survival and the proliferation of cultured cancer cells. We will determine the mechanism on how cancer cells but not normally proliferating cells accumulate SAICAR, while testing the relevance to tumor growth in vivo. The outcome will determine whether the SAICAR accumulation can be a potential therapeutic target.